A multimodal MPRA platform to study regulatory sequence function

SUMMARY
The overarching goal of the proposed research is to develop tools capable of elucidating the mechanisms and
grammar of how the regulatory elements in the genome encode the interactions between chromatin, regulatory
factors, and transcriptional processes that underlie the precise regulation of transcription. To study the
mechanisms of how individual regulatory elements regulate different aspects of transcription, we propose to
develop technology based on massively parallel reporter barcoding strategies to allow interrogation of the
different molecular aspects of regulatory element function, either in isolation or combination, while separated
from the variegating influence of their genomic sequence environment. The new assays will enable simultaneous
measurements of the effect of sequence perturbations on chromatin state, DNA-protein interactions, 3D
chromatin interactions, and promoter-proximal aspects of transcription regulation (initiation, pausing, pause
release). The new methodology will be validated against the effects of introducing corresponding mutations at
endogenous genomic loci by genome editing. To demonstrate the use of these novel assays that will
simultaneously provide orthogonal data on the functional characteristics of thousands of enhancer perturbations,
we will test the hypothesis that individual enhancers may exert their function through modulation of different
transcriptional mechanisms. This will include testing whether individual enhancers affect transcription initiation
or promoter pause release, and whether enhancers function during cellular differentiation or acute stimulus
responses. To this end, we will establish a process to integrate the MPRA reporters into defined loci in human
iPS cells, and develop software to facilitate reporter sequence design, data analysis and integration with
genome-wide profiling data.

Public health relevance
PROJECT NARRATIVE Transcription is a key step with which the cell decodes the information encoded in the genome. Therefore, a thorough understanding of the mechanisms that regulate transcription is essential to be able to model how genetic variants affect gene regulation and contribute to disease. Studies in this proposal seek to develop new methods to interrogate how the DNA sequence of gene regulatory regions in the genome affects different steps of the transcription process.